Investigating ancestry-specific genetic variation associated with HLBS phenotypes in diverse patient biobanks

PROJECT SUMMARY/ABSTRACT
Cardiovascular diseases are not only the leading cause of mortality in the world, but they also lead to almost
twice as many deaths in Black adults compared to White adults in the United States. Similar drastic health
disparities exist for many other heart, lung, blood, and sleep (HLBS) disorders. Acknowledging that social
determinants of health play a significant role in these disparities, we cannot overlook the biases that have
perturbed existing genomic studies on which we base the development of precision medicine technologies. Of
the ~6,300 studies currently compiled in the genome-wide association studies (GWAS) catalog as of March 2023,
~95% of all GWAS participants are of European (EUR) ancestry with less than 1% of participants being of African
American (AFR) ancestry. Attempts to translate genetic research findings into clinical practice may be not just
incomplete, but dangerously mistaken and misapplied. With the advent of large and diverse patient biobanks,
there needs to be a targeted focus on studying genetic variations specific to ancestries that are too often
understudied. The Penn Medicine BioBank serves as an ideal discovery vehicle for this purpose with a repository
of genotype, whole-exome sequencing, and electronic health record (EHR) data as well as one of the largest
AFR populations at any single-institutional medical biobank in the US, to our knowledge. We hypothesize that
by using a genome-first AFR-specific approach, we will identify significant genetic associations for HLBS
disorders that would have otherwise been missed by previous EUR-dominant studies and future multi-ancestry
approaches. We will curate a list of AFR-specific predicted loss-of-function and missense variants, and then
through HLBS-focused phenome-wide association studies, we will characterize the clinical manifestations of the
diseases caused by these protein-altering variants. Furthermore, genome-wide association studies will be used
to identify genetic loci with significant discrepancies in effect across ancestries and uncover variabilities in HLBS
disease prevalence. To investigate these ancestry-specific risk loci, we will employ local ancestry inference to
study ancestry-dosage effects and construct haplotypes to uncover drivers of the observed phenotype
associations. This proposed project has the potential to broaden our understanding of genetic risk for HLBS
disorders and significantly impact the development of diagnostic and therapeutic methods. Beyond that, our work
embodies the vision that the advancement of personalized medicine should benefit every patient of every
ancestry and socioeconomic background.

Public health relevance
PROJECT NARRATIVE A significant contributor to the unsettling fact that cardiovascular diseases kill almost twice as many Black adults compared to White adults in the United States, is the lack of equitable population representation in genomic studies. I propose to address this significant shortcoming by using an African ancestry-focused approach to identify genetic variations associated with heart, lung, blood, and sleep phenotypes and elucidate how both individual and local ancestry contributes to disease risk. This work has the potential to expand our knowledge of genetic risk in a historically under-represented population and advance the development of effective and equitable precision medicine technologies.